TOXICITY STUDIES OF 2-, 4-CHLORONITROBENZENE

The objective of this project is to develop, evaluate, and report the methodology and results for generation and monitoring techniques necessary for conducting prechronic inhalation studies with 2-chloronitrobenzene and 4-chloronitrobenzene.